Caspase-9 as a nodal point connecting necrotic and apoptotic cell death in myocardial infarction

The primary cardiac event in MI is cell death. Genetic studies in mice have established that most cardiomyocyte
death during reperfused MI (MI/R) occurs through regulated cell death programs. This suggests that it should be
possible in concept to limit cardiomyocyte death during MI/R to obtain the full benefit of reperfusion in maintaining
cardiac function. A significant obstacle in achieving this goal, however, is that cardiomyocyte death in MI/R is
mediated by several regulated apoptosis and necrosis programs, and the mechanisms that link these programs
to produce an integrated cell death response remain poorly understood. This gap in knowledge has been a
critical impediment for the rational design of therapies to limit cardiac damage during MI/R. Accordingly, a goal
of our lab has been to understand the molecular framework that connects cell death programs in MI/R. Our
preliminary studies have identified caspase-9 as an important link between apoptosis and necrosis programs
during MI/R. The canonical role of caspase-9 in apoptosis is to activate downstream procaspases-3 and -7.
However, we have identified a new pathway in which caspase-9 mediates cardiomyocyte necrosis during MI/R.
In contrast to caspase-9-mediated apoptosis, caspases-3/7 are dispensable for caspase-9-mediated necrosis
indicating the distinctness of the two pathways. However, as in apoptosis, caspase-9 enzymatic activity is
required. To further dissect the pathway, we performed a proteomics-based screen for procaspase-9 interacting
proteins in the heart during MI/R, which revealed proteins known to be involved in various aspects of necrosis.
Thus far, we have focused on one procaspase-9 interactor, SERCA2a, which we hypothesize functions
downstream of caspase-9 to mediate cell-intrinsic killing. Our data suggest that caspase-9 cleaves SERCA2a
during MI/R disabling its function consistent with prior genetic studies showing that SERCA2a loss exacerbates
cardiomyocyte necrosis and infarct size. We believe, however, that the relationship between procaspase-9 and
SERCA2a is more complex. In addition to caspase-9 inducing SERC2a loss, our data suggest that SERCA2a
loss may contribute to caspase-9 activation through Ca2+ overload. Thus, we hypothesize that a bidirectional
mutually-reinforcing relationship exists between caspase-9 and SERCA2a and contributes to cardiomyocyte
necrosis and infarct generation in MI/R. This project investigates critical aspects of the caspase-9-mediated
necrosis pathway including activation mechanisms, downstream signaling, the relationship of the pathway to cell
death programs thought to be involved in MI/R, and whether this pathway can be therapeutically inhibited to limit
infarct size. Aim 1. To genetically dissect the caspase-9 necrosis axis during MI/R in vivo. Aim 2. To delineate
the bidirectional regulation between caspase-9 and SERCA2A in cardiomyocyte necrosis during MI/R. Aim 3. To
assess the therapeutic benefit of specifically inhibiting procaspase-9 during MI/R using a cell permeable peptide
derived from an endogenous procaspase-9 inhibitor. These studies define a novel cell death pathway that
appears important in MI/R and may provide the basis for a new therapeutic approach to limit infarct size.

Public health relevance
The canonical role of caspase-9 is to mediate apoptosis. We have discovered a new pathway in which caspase- 9 mediates necrosis. Our in vivo data suggest that this pathway is important in cardiomyocyte death during myocardial infarction with reperfusion. This project delineates key aspects of the pathway and investigates whether its therapeutic inhibition could provide the basis for a new therapy to limit cardiac damage during myocardial infarction.